ENCODE Mapping Center-A Comprehensive Catalog of DNase I Hypersensitive Sites

ABSTRACT The overall mission of this Mapping Center is to create and disseminate open access, comprehensive, high-­quality, high-­resolution reference maps of DNase I hypersensitive sites (DHSs) in the human and mouse genomes, at previously unattainable levels of cellular and anatomical definition. Regulatory DNA is actuated in an exceptionally state-­specific manner;? accordingly, achieving a comprehensive map of DHSs necessitates the interrogation of an expansive and finely partitioned range of cell and tissue samples. Progressive technical improvements and recent innovations have resulted in dramatic (>100x) decreases in requisite input biological sample quantities coupled with equally dramatic (>100x) increases in assay throughput, and corresponding decreases in the incremental cost of generating reference-­quality DHS maps. These advances have in turn opened the possibility of systematically addressing all well-­defined physiologically and disease-­relevant anatomic and cellular compartments. Four major Specific Aims are targeted: (1) To create open access, comprehensive high-­quality, high-­ resolution reference maps of human DNase I hypersensitive sites;? (2) To create and disseminate comprehensive high-­quality, high-­resolution reference maps of mouse DNase I hypersensitive sites;? (3) To maintain and disseminate reference indices of DNase I hypersensitive sites and footprints in the human and mouse genomes;? and (4) To enable large-­scale intake of Consortium and Community samples for high-­quality, high-­throughput DHS mapping.

Public health relevance
RELEVANCE DNaseI hypersensitive sites mark the locations of regulatory DNA in the genome, and have proven to be of remarkable utility for understanding diverse aspects of genome function and the genetic and mechanistic bases of both normal physiology and disease. Creating detailed, comprehensive maps of regulatory DNA is vital to unlocking the potential of the genome to inform medical decision making, guide development of new medicines, and impact human health.